Discovering mechanisms of neuroblastoma tumorigenesis to improve patient outcomes

Project Summary
After stunning improvements in patient outcomes for most childhood cancers in the latter half of the last
century, cure rates have plateaued. Children with metastatic solid malignancies continue to have a less than
50% chance of survival despite being treated with highly intensive cytotoxic therapies. Neuroblastoma (NB), a
diverse malignancy affecting very young children that arises from the developing sympathetic nervous system,
is responsible for a disproportionate amount of morbidity and mortality attributable to childhood cancer and is
the main focus of the Maris translational research program. Our primary motivation is to improve patient
outcomes, and we also deem NB an outstanding model of cancer in general, such that discoveries of basic
mechanisms of tumorigenesis are broadly applicable to other human malignancies. Over the next seven years,
the Maris lab will seek to substantively improve cure rates for patients with through a multidisciplinary and
collaborative research program. Our broad goal is to discover the fundamental mechanisms that subvert
normal neural development and orchestrate NB tumorigenesis, and then to translate this knowledge into
patient-specific therapies that will be more effective and less toxic. We thus have a comprehensive approach
with six highly integrated major research efforts planned over the next seven years. 1) Genetic susceptibility to
NB. Our lab has discovered the majority of NB predisposition genes using genetic approaches. We will now
define the mechanisms by which DNA variation cause malignant transformation via epistatic deregulation of
normal developmental pathways using epigenomics approaches. 2) NB genomics and clonal evolution. Our lab
has led the collaborative efforts to define the genomic landscape of diagnostic high-risk NB. We will now focus
on NB as a dynamic ecosystem, defining how tumors adapt to the selective pressure of therapy. 3) NB drug
development. The Maris lab has utilized genomic data and genetic screens to define oncogenic vulnerabilities,
and many of these have been translated to the clinic. We will now focus on defining mechanisms of therapy
resistance to both standard of care agents and the targeted therapies we develop. 4) Immunogenomics. The
Maris lab has used an integrative approach to discover several new immunotherapeutic targets in NB. We will
now intensively focus on developing antibodies, antibody drug conjugate and adoptive T-cell therapies to these
targets designed to eradicate NB safely. 5) Precision NB therapies. We have developed biomarker-directed
clinical trials for children with relapsed NB, and will continue our efforts here both in the relapse and newly
diagnosed setting using clinical trials designed to enrich for patients most likely to benefit. We think that our
research program proposes a variety of innovative experimental strategies to uncover basic mechanisms of
oncogenesis, kinome reprogramming, epigenetic adaptation and immune evasion, and is steadfastly
translational. The significance of the proposed program is the discovery of fundamental mechanisms of NB
tumorigenesis that will lead to markedly improved probability of cure coupled with reduced morbidity.

Public health relevance
Project Narrative The research program proposed here is relevant to public health because it seeks to discover fundamental principles of cancer etiology, evolution, and response to therapy, focusing on the childhood malignancy neuroblastoma. The research is highly relevant to the NIH mission and the urgent unmet need of developing rational evidence-based therapeutic strategies to reduce the health burden of cancer. The proposed research is designed to discover the basic oncogenic mechanisms of high-risk neuroblastoma that are amendable to novel therapeutic strategies designed to dramatically improve cure rates with decreased morbidity.